Michigan Alzheimer's Disease Research Center-Supplement

ABSTRACT
Health disparities in ADRD continue to be a major social and health justice challenge that affect the most
vulnerable population in the USA. The fact that Black / African Americans and Latinos are more likely to not
receive a dementia diagnosis and experience discrimination when visiting a physician indicates that disparity in
ADRDs may be greater than estimated. The Michigan Alzheimer’s Disease Research Center (Michigan ADRC)
was refunded in September 2021 as a tri-university consortium that brings together the three major research
universities in Michigan to create a novel statewide initiative: University of Michigan (U-M), Michigan State
University (MSU) and Wayne State University (WSU). The scope of this proposal remains well within the
Michigan ADRC’s goal to “Foster, Catalyze and Perform Research of the Highest Potential Impact in AD and
Related Neurodegenerative Disorders” and specifically for the Michigan ADRC’s Clinical Core aim to “Enhance
Diversity in Aging and Dementia Research.” Building on our success, we will establish a Latino Cohort remote
enrollment site in Grand Rapids, Michigan. To achieve this goal, we propose to 1) leverage established
community partnerships to address health disparities in ADRD through the training of community health
workers and personnel at community healthcare clinics about early signs of cognitive impairment, 2) increase
participation of community dwelling older Latino adults in ADRD research, 3) profile plasma biomarker of
community dwelling older Latino adults with and without cognitive impairment. The ultimate goal is to establish
a representative Latino Cohort that enhances the geographical representation of Latinos in ADRD research.
Importantly, using a Health Equity Framework, we will establish a community dwelling older Latino cohort while
enhancing resources and access to healthcare within underserved communities and create a critically
important statewide dementia-focused resource that serves researchers, trainees, health care professionals
and the public.

Public health relevance
PROJECT NARRATIVE – OVERALL Alzheimer's disease and related dementias (ADRD) represent one of the greatest health problems in the United States and the state of Michigan. Building on longstanding strengths in dementia research, outreach and training at three universities working as a consortium, the Michigan ADRC will lead a regional effort to identify, understand and modulate the many factors beyond β-amyloid that contribute to brain dysfunction and degeneration in ADRD.